Visualizing trigeminal neuralgia at 7 Tesla: Advancing etiological understanding and improving future clinical imaging protocols

Project Summary
Trigeminal Neuralgia (TN) is one of the most painful disorders ever identified and affects 4.3 out of every
100,000 people in the US. In its most typical form, it causes brief attacks of intense shock-like pain on one side
of the face. Although it is known to be associated with the trigeminal or 5th cranial nerve, its overall etiology
remains poorly understood. A multitude of pharmacological and surgical methods have been used to treat
TN, with varying levels of long-term efficacy, but treatment remains challenging given that TN pain may be
caused by any of a myriad of underlying abnormalities that may not always be identifiable using current
clinical workups. Clinically, magnetic resonance imaging (MRI) is used to detect neurovascular
compression (NVC), conventionally understood to be a main cause of TN, and to rule out other potential
etiologies such as lesions or multiple sclerosis. However, pain eventually recurs in nearly half of patients whose
NVC was treated surgically, and NVC is often identified in people who do not have TN. Although current MRI
protocols are important in the pre-surgical assessment of NVC, they likely lack the resolution, quantitative
accuracy, and scope required to simultaneously interrogate the entire trigeminal sensory pathway, as well as
the brain networks associated with the sensation, evaluation, and modulation of pain that may also contribute to
TN. There remains a critical unmet need to comprehensively study the regions and networks implicated in TN
and reliably and accurately identify the true cause of pain in TN patients. MRI at ultrahigh magnetic fields such
as 7 Tesla (7T) provides increased signal to noise ratio, which yields images with exquisite resolution that can
elucidate subtle anatomical, vascular, microstructural, and functional alterations in unprecedented detail.
Therefore, we will perform a systematic prospective study of TN patients (half with identified NVC and half
idiopathic) and matched healthy controls using a state-of-the-art, TN-specific, multimodal 7T MRI protocol
composed of high-resolution structural, vascular, diffusion, and functional imaging sequences. We propose
three aims directed towards our central hypothesis: 1) To develop new imaging techniques to better visualize
all possible brain regions implicated in TN; 2) To perform qualitative and quantitative analysis of 7T
multimodal images to characterize the structural integrity of the trigeminal sensory pathway along its entire
length from the trigeminal ganglion to the primary somatosensory cortex; 3) To perform whole-brain structural
and functional network analyses to reveal abnormalities in networks associated with pain sensation and
modulation in TN patients; and 4) To evaluate translation of our 7T findings to 3 Tesla clinical scanners.
Successful completion of this study should yield imaging markers that are tightly linked to the pathophysiology
of TN, and could lead to a more complete understanding of TN, ultimately resulting in more targeted and
effective treatments for this painful affliction.

Public health relevance
NARRATIVE Trigeminal neuralgia (TN) is a mentally and physically incapacitating chronic facial pain condition characterized by sudden, shock-like pain. Treatment of TN is challenging as the root cause of the condition is often unclear, and can result from a range of nerve and brain abnormalities that are non-specific to TN, and may be difficult to detect using standard clinical imaging methods. This study will develop and use ultrahigh field (7 Tesla) multi- modal magnetic resonance imaging to visualize and quantify nerve and brain alterations associated with TN and evaluate translation to clinical MRI scanners, thereby providing a more complete understanding of the etiology of the disease and driving more targeted treatment paradigms.